Optimizing co-adaptation in motor BCIs by uncovering brain-decoder interactions

Project Summary
Brain-computer interfaces (BCIs) hold great promise to restore movement to paralyzed people. But BCIs
cannot yet provide reliable performance across the long timespans and varied settings needed for real-
world applications. Maintaining robust BCI performance over many days is challenging because brains are
highly plastic. Plasticity during extended BCI practice leads to changes in how neural activity relates to move-
ments—the brain’s encoding of BCI movement. How the brain’s encoding changes is influenced by the decod-
ing algorithm used by the BCI to map neural activity into movement. These interactions create complex dynam-
ics where methods that improve performance in the short term may produce problems longer-term. Indeed, our
preliminary data suggests current adaptive decoding methods used to maintain performance over time lead the
brain to form encoders where very few neural signals control movements, which make BCI vulnerable to cata-
strophic failure with loss of a single neural signal. The long-term vision of this proposal is to expand the engi-
neering tools available to produce robust, high-performance BCIs by building tools that account for and even
leverage plasticity. To enable this vision, this proposal will test the overarching hypothesis that decoder-en-
coder interactions can be used to jointly optimize BCI performance and robustness. We focus on robustness of
BCI systems to signal loss and changes in task context. We will use an animal model where monkeys move
cursors with activity from motor cortices, which has repeatedly informed clinical BCIs. We will leverage novel
micro-electrocorticography implants that allow us to longitudinally monitor and manipulate cortical dynamics to
advance our understanding of plasticity in multi-day (10 days) BCI training. We will test our overarching hy-
pothesis across three aims. If our hypothesis is true, there must be relationships between decoders and prop-
erties of encoders that are related to robustness. Aim 1 will determine whether decoders influence how infor-
mation is structured in an encoder, which influences how robust BCIs are to signal loss. Aim 2 will determine
whether decoders influence the specificity of learned encoders to BCI movements, which influences how ro-
bust BCIs are to changes in tasks. Finally, if our hypothesis is true, it requires computational tools that can opti-
mize multiple goals in a BCI. Aim 3 will test a novel decoder training paradigm we developed that can consider
multiple objectives. We will compare our novel method to established single-objective methods to determine
whether multi-objective methods can improve robustness without compromising performance. Across all aims,
we will perform offline analyses and online perturbations to measure robustness to signal loss and changes in
neural state and behavioral task. Together, these studies will identify how critical plasticity computations can
be influenced through the decoder. Pairing this with tests of novel decoding methods will establish new frame-
works to build encoder-informed decoders and pave the way for BCIs that can leverage brain plasticity.

Public health relevance
Project Narrative This proposal will advance our understanding of how the brain changes when someone uses a brain-computer interface for many days, and how brain changes are influenced by the device. Understanding how devices influence the brain is an important step towards building engineering tools that can assure brain-computer interface therapies provide robust performance over time. The outcomes of this proposal have the potential to enable next-generation brain-computer interfaces that can reliably restore movement to paralyzed people for long periods of time across varied tasks.